SYNTHESIS OF INHIBITORS OF BIOTIN CARBOXYLASE

This research focuses on the synthesis of novel inhibitors of biotin carboxylase derived from e. coli. Mass spectrometry is used to monitor the synthetic chemistry.